REGIONAL CEREBRAL CIRCULATION AND METABOLISM

This is an omnibus project that covers a variety of studies on development, validation, refinement, and applications of methods to determine the basic biochemical and physiological mechanisms underlying the regulation of cerebral blood flow (CBF) and energy metabolism in response to functional activation of neural pathways in the nervous system. Most of the work in this project during the last year has been directed at identifying the biochemical mechanisms of regulation of CBF. Results this year have shown that there are multiple mechanisms operating at different relay stations along a pathway. Adenosine receptors in vascular smooth muscle are involved in the regions of the first synapses. Adenosine produced by altered energy metabolism during functional activation initiates a cascade of events that act on the adenosine receptors and ends in opening of K+ channels, membrane hyperpolarization, and smooth muscle relaxation in the cerebral blood vessel walls. At later stations in multisynaptic pathways nitric oxide (NO) produced by neuronal NO synthase appears to play a role.PublicationsSokoloff, L.: Energetics of functional activation in neural tissues. Neurochem. Res. 24: 321-329; 1999.Sokoloff, L., Kuang, T-Y, Horinaka, N., and Kennedy, C.: Are cerebral circulation and energy metabolism really tightly coupled? In: Krieglstein, J. (Ed.): Pharmacology of Cerebral Ischemia 1998. medpharm Scientific Publishers, Stuttgart, 1999, pp. 3-16.Madsen, P. L., Cruz, N. F., Sokoloff, L., and Dienel, G. A. Cerebral oxygen/glucose ratio is low during sensory stimulation and rises above normal during recovery: Excess glucose consumption during stimulation is not accounted for by lactate efflux from or accumulation in brain tissue. J. Cereb. Blood Flow Metab. 19: 393-400; 1999.Sokoloff, L.: Mapping cerebral functional activity with radioactive deoxyglucose.In: Adelman, G. and Smith B. (Eds.): Encyclopedia of Neuroscience, 2nd Edition.Elsevier, Amsterdam, 1999, pp. 1092-1101.Sokoloff, L.: Mechanisms of regulation of cerebral blood flow. In: Ito, U., Fieschi, C., Orzi, F., Kuroiwa, T., and Klatzo, I.(Eds.):Maturation Phenomenon in Cerebral Ischemia III. Defensive Mechanisms versus Apoptosis; Neuronal Recovery and Protection in Infarction. Springer, Berlin, 1999, pp. 291-307.Elman. I., Sokoloff, L., Adler, C.M., Weisenfeld, N.,and Breier, A.: The effects of pharmacological doses of 2-deoxyglucose on cerebral blood flow in healthy volunteers. Brain Res. 815: 243-249; 1999.Nakao, Y., Kuang, T.- Y., Cohen, D. M., Pettigrew, K. D., and Sokoloff, L.: Cerebral blood flow responses to somatosensory stimulation are unaffected by scopolamine in the unanesthetized rat. J. Pharmacol. & Exper. Therap. 290: 929-934; 1999. - iodoantipyrine; local cerebral blood flow; 14C deoxyglucose; adenosine receptors; adenosine; K+ channels; cerebral blood vessels